SUMMER RESEARCH FOR UNDERGRADUATES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We are running a program that provides undergraduate students with experience in state-of-the-art proteomics and mass spectrometry analysis. We have generated support for this effort though both intramural and NIH funds. The program runs for 10 weeks and provides lodging, transportation, a stipend, and some laboratory consumables.